KEEP: Kentucky Environmental Education Pipeline, A program to retain a diverse and equitable scientific trainee pipeline

ABSTRACT
The KEEP: Kentucky Environmental Education Pipeline will create a paid immersive undergraduate
environmental health focused summer research experience that targets enrollment by URM and economically
disadvantaged students. Nearly 60% of students who enter college with the goal of majoring in a STEM field end
up graduating in a non-STEM field or leaving without a degree. This attrition is especially severe in students from
underrepresented and historically marginalized communities. Among the major reasons for such a high dropout
from STEM programs are limited career counseling, limited institutional support, and an academic culture that is
unwelcoming or outright hostile to unique circumstances and lived experiences. The KEEP program will facilitate
the development of student identity as scientists, create lasting support structures, and connect student research
to local communities. The KEEP program will focus on the following Specific Aims:
Aim 1: Create and administer a 10-week on-site summer undergraduate research program for UofL
students in the broad field of environmental health sciences. The KEEP program includes mentored research as
well as a community led environmental sampling bootcamp (all mentors also invited), weekly instruction in
biostatistics concepts and methodologies, and dissemination via undergraduate research day participation as
well as Posters-At-The-Capital and regional Ohio Valley Society of Toxicology meeting participation.
Aim 2: Enrich undergraduate student development through continuing academic and career
mentoring, professional development activities (ex: resume building and personal statement construction),
exposure to a broad variety of environmental health research seminars, and weekly cohort building activities.
Aim 3: Evaluation of student outcomes including recruitment, participation, satisfaction, and tracking
of academic progress toward matriculation. We will utilize existing infrastructure associated with the UofL CIEHS
and Office of Undergraduate Research and Creative Activities as well as the UofL Cards Analytics office.

Public health relevance
NARRATIVE: KEEP: Kentucky Environmental Education Pipeline program will recruit and train undergraduate student researchers from historically marginalized populations for careers within the field of environmental health sciences. Key to the mentorship associated with this summer research opportunity program, we will offer access to specialized skills training sessions via ‘boot camps’ including a community-embedded air/soil sampling field trip with integrated report back organized and administered via the NIEHS funded Center for Integrative Environmental Health Sciences Community Outreach core. Faculty mentors and/or program directors will continue to provide career coaching and personalized mentorship until matriculation so that participants are fully integrated into an ongoing supportive community focused on degree completion, timely application to competitive graduate and professional school programs, and ultimately biomedical careers in environmental health sciences.